AUTOTRANSPLANTATION OF ADRENAL MEDULLA TO BRAIN FOR PARKINSON'S TREATMENT

This study will evaluate the effectiveness of autotransplantation of the adrenal medulla to the caudate nucleus for treatment of medically intractable and disabling Parkinson's disease.